RESEARCH TRAINING ON ALCOHOL ETIOLOGY AND TREATMENT

APPLICANT'S ABSTRACT: The purpose of this program, to be implemented at the Research Institute on Addictions (RIA), is to provide specialized postdoctoral training for individuals seeking to pursue a career in alcohol research. The proposed program focuses on providing quality research training in two primary areas: (1) etiology and course of alcohol use and misuse and (2) treatment for alcohol use disorders. The goal of the program is to produce scientists who will be thoroughly trained to teach and conduct systematic research on these and related topics. The proposed program is characterized by several strengths. First, an interdisciplinary approach will be used as the framework for the training program. The Core and Associated Faculty include representation of such diverse yet complementary fields as psychology, sociology, epidemiology, biochemistry, criminal justice, social work, internal medicine, and psychiatry. Second, the faculty are all experienced and productive researchers. All are actively involved in relevant research endeavors, and the majority are serving as Principal investigator (PI) on federally-funded projects. Third, RIA is in a position to provide a variety of supports requisite to the research training enterprise, including a specialized library, a state-of-the-art computer center, an animal care facility and associated laboratories, laboratories for human studies, and an outpatient clinical research treatment center. Finally, RIA has an extensive history of providing postdoctoral training. The faculty will provide training for six postdoctoral fellows. Trainees will be assigned a specific preceptor, based on their research interests. The preceptor will provide training in conceptualization, methodology, and ethics of research in the trainee's primary area of study. The program also will include several required seminar components: Foundations of Interdisciplinary Alcohol Research, Current Alcohol Research (including a monthly journal club), Grant Writing, and Professional Issues and Career Development. Trainees also will meet quarterly with the Core Faculty Supervisory Committee and attend RIA's Seminar Series, which includes statistics workshops.